Thalamocortical interactions and the effect of thalamic stimulation on sleep oscillations

PROJECT SUMMARY
The thalamus plays a key role supporting sleep. The thalamus is also a target for therapeutic electrical
stimulation, but the effect of thalamic stimulation on sleep has not been investigated.
We hypothesize that thalamic stimulation could both elicit and disrupt sleep oscillations, particularly spindles,
depending on stimulation location and timing. We also hypothesize that thalamic stimulation affects sleep
integrity. We will study two unique complementary patient groups to obtain direct evidence in humans of how
thalamic stimulation affects sleep.
First, in 50 patients with medication refractory epilepsy with semi-chronic depth-electrodes clinically implanted
to delineate their epileptic focus, we will compare stimulation delivered to the thalamus and to other regions. We
will assess the spatial extent across the brain of stimulation evoked spindles under each condition.
Then, with our closed-loop system, spindles will be detected, and stimulation delivered in real-time. We will study
under which circumstances stimulation disrupts spindles. We expect thalamic stimulation to have a broad effect
compared to a local effect of neocortical stimulation. We will also relate spindle disruption to other oscillations.
In another 25 patients with chronically implanted stimulator devices in the thalamus (to control their epileptic
seizures) we will study their brain activity following therapeutic thalamic stimulation during sleep at home. We
will evaluate whether stimulation evokes spindles and produces micro-arousals.
For therapeutic thalamic stimulation to fully benefit the patients, it is necessary to understand the effect of
stimulation on sleep oscillations and whether there are consequences for sleep integrity. This project is the first
step to unravel the effect of thalamic stimulation on sleep oscillations in humans. This will improve our
understanding of the thalamus as relay of sleep oscillations and provide for the first-time direct evidence in
humans of the implications of chronic thalamic stimulation for sleep. This new direction for research is essential
for understanding current therapies and moving toward new therapies for a wide range of neurological and
neuropsychological disorders.

Public health relevance
PROJECT NARRATIVE The thalamus plays a key role in supporting sleep and is also a target of therapeutic stimulation. This project will investigate when, where, and how electrical stimulation delivered to the thalamus in humans elicits or disrupts sleep oscillations and whether stimulation affects sleep integrity. This new direction for research is essential for understanding current therapies and moving toward new therapies for a wide range of neurological and neuropsychological disorders.